CANCER RISK ASSESSMENT AND GENETIC SCREENING IN CANCER PRONE FAMILIES

We hereby submit the protocol to the CRC with an amendment to have the acquisition, handling and processing of blood samples performed by personnel in the Clinical Research Center. The overall purpose of this study is to bank DNA samples in parallel with well characterized pedigrees of participants with hereditary cancer. Blood samples will be used to perform genetic testing using markers for specific cancers.